IN VITRO MEASUREMENT OF BINDING OF SELF AND ANTIGENIC PEPTIDES TO MHC MOLECULES

The objective of this work has been to understand the details of the interaction of self and foreign antigenic peptides with the MHC class I molecule by detailed kinetic and equilibrium binding methods. In addition to allowing us to understand the underlying biochemical rules that govern protein/peptide interactions, these studies provide specific information on particular MHC/peptide interactions which govern the initiation of the immune response. In the past year we have further improved upon quantitative assays, examined a number of protein/peptide interactions, including antibody/peptide interactions. Understanding these processes on a biochemical and biophysical level provides a basis not only for understanding the binding reactions, but also offers an opportunity for rational design of peptide analogs that might be useful in immunization and intervention in autoimmune disease.